STORAGE AND DISTRIBUTION OF CLINICAL AGENTS

To support the conduct of clinical trials, a non-research, repository service contract to provide for receipt, storage, distribution and final disposition of all clinical agent supplies in support of the CTEP drug development program is required. The objective of the “Storage & Distribution of Clinical Drugs” contract is to provide support to the Pharmaceutical Management Branch (PMB) within CTEP/ DCTD , in maintaining and operating a clinical agent repository facility and project team to receive, store, distribute and dispose of clinical agent supplies for the conduct of clinical trials world-wide.